CORE--MEDIA PREPARATION

The great diversity of techniques used in Cancer Research demands equally diverse reagents and facilities. While the preparation of growth media is not technically difficult, the scale of our needs requires an efficient, centralized facility. The media preparation needs for the Program and Core (Monoclonal Antibody and Cell Production Core) will be provided by the Media Preparation Facility (Core D). This facility will prepare both liquid and solid media for the growth of bacteria and yeast, plus tissue culture media, salts, and buffers. In addition, sterile glassware and supplies will be provided for the Projects in the Program.